Role for ICP0 and UL55/UL13/Us10 in protein degradation in neurons and reactivation of HSV from latent infection

The human pathogen, Herpes Simplex Virus type 1 (HSV-1), establishes a latent infection only in neurons and
can reactivate to result in the production of infectious virus for transmission to a new host. Reactivation can
result in lesions at the body surface and encephalitis, in additional to potentially promoting the development of
neurodegenerative disease. HSV-1 has mechanisms to degrade certain host proteins that restrict virus
replication in non-neuronal cells, which permits the virus to overcome intrinsic host immunity mediated by
restriction factors. However, it is currently unknown what proteins are degraded by the virus in neurons.
Understanding proteins targeted for degradation in neurons is important to identify proteins that restrict the
virus for either entry into latency or form a barrier to reactivation. One viral protein, ICP0, is an E3 ubiquitin
ligases that mediates degradation of host proteins involved in restricting replication. Surprisingly, we have
identified a complex containing pUL55, pUL13, and pUS10 that acts redundantly with ICP0 to degrade host
proteins in non-neuronal cells. We hypothesize that ICP0 and pUL55/pUL13/pUS10 target specific host
proteins for degradation in neurons following HSV-1 infection to enable viral gene expression and modulate the
latency/reactivation cycle. The goals of this project are to identify host proteins degraded in neurons and the
contribution of the pUL55 complex and ICP0 to both protein degradation in neurons and reactivation. Based on
our preliminary data, we hypothesize that ICP0 and pUL55 function independently in neurons to promote viral
gene expression. We will use the expertise of the Cliffe lab to investigate HSV neuronal infection, along with
the Crump lab to carry out quantitative tandem mass spectrometry on infected cells. In aim 1, using both
murine and human neurons, we will determine proteins degraded following HSV-1 neuronal infection and the
role of ICP0 and the pUL55 complex and their potential role in restricting neuronal infection. In aim 2, we will
use our validated model of HSV latency to determine the exact contribution of ICP0 and pUL55/pUL13/pUS10
to reactivation, using both deletion viruses in addition to shRNA depletion of the proteins to understand their
role solely in reactivation. Therefore, this proposal is significant and innovative because it will create a novel
dataset of proteins degraded in neurons and test the hypothesis that HSV has evolved multiple strategies to
degrade host proteins in neurons. In addition, we will determine the contribution of both ICP0 and the pUL55
complex solely in neuronal infection and reactivation. Overall, these aims will provide insights into the
mechanisms of HSV-1 latency in neurons and may lead to the development of novel therapeutic strategies to
prevent reactivation from occurring.

Public health relevance
Herpes simplex viruses persists for life in neurons as a latent infection and can reactivate to cause disease. The aims of this study are to identify host proteins that are targeted for degradation following infection and the contribution of viral proteins in both degradation and reactivation. Our long-term goals are to understand the consequence of HSV persistent neuronal infection and identify new targets for therapeutics that prevent reactivation of HSV.